Diversity Supplement for Jenny Lutshumba

Abstract
There is a sex-based difference in the etiology of Alzheimer’s disease (AD) and Vascular
contribution to cognitive impairment and dementia (VCID), the two most common forms of
dementia. Females have a higher incidence of Alzheimer’s disease and related dementias
(ADRD), as well as sex-based differences in cardiovascular risk factors for dementia. In a
subgroup of participants from the risk reduction for Alzheimer’s disease (rrAD; NCT02913664)
clinical trial at baseline, we found a sex difference in plasma AD biomarkers. Females had
higher levels of total tau and total tau/Ab42 while pTau181 was higher in males, with no
difference found in the Ab42/40 ratio. VCID biomarkers also show no sex-based differences.
There was however a sex-based difference in the association between AD and VCID
biomarkers. In females, VEGF-D associated with total Tau, while in males VEGF-D associated
with pTau181 and pTau181/Ab42, and bFGF associated with Tau/Ab42. These preliminary
findings support a sex-based difference of biomarkers in the pathogenesis of VCID and AD in
cognitively healthy older adults. However, there is still a reluctance in human studies to stratify
cohorts by sex. Moreover, there is great appreciation for the importance of the crosstalk
between the systemic immune system and the brain pathologies in ADRDs. However, the role of
systemic inflammation in the pathogenesis of ADRDs remains under-explored. The purpose of
the proposed supplement is to investigate the sex effects of independent and combined effects
of Intensive pharmacological Reduction of Vascular Risk factors (IRVR) i.e. hypertension and
dyslipidemia and aerobic Exercise (Ex) on inflammation and cognitive function. Here, we will
test the hypothesis that females in IRVR+Ex will ameliorate AD/VCID-associated biomarkers
and pro-inflammatory cytokines and associate with better cognitive function by testing the
following aims: Aim1: To determine whether there is a sex difference in inflammatory cytokines
and injury markers in the plasma between IRVR+Ex and IRVR or Ex and their association with
AD/VCID biomarkers. Aim2: To determine whether there is a sex-mediated amelioration in
alteration in peripheral immune cells in IRVR+Ex compared to IRVR or Ex.
The long-term goal of this project is to identify inflammatory biomarkers that will be predictive of
ADRD in males and females.

Public health relevance
Diversity Supplement on Funded Grant RF1 AG084134 “Biomarkers to Track Effective Interventions That Delay Dementia Onset In Participants of the "Risk Reduction for Alzheimer's Disease (rrAD)" Trial” Project Narrative: This proposed supplement aims to identify sex differences in immune dysregulation and inflammatory cytokines in subjects with cardiovascular risk factors (i.e hypertension and dyslipidemia) and at risk for Alzheimer’s disease and related dementias (ADRD) and determine if an effective lifestyle intervention will delay the development of dementia. Additionally, this project will help refine the fluid biomarkers and distinguish between males and females with high risk for ADRD, consequently improving diagnosis and drug development for Alzheimer’s disease and related dementias.